Pathological Mechanisms of Human Cerebellar Malformations

PROJECT SUMMARY
While the cerebellum's role in motor function is well recognized, the cerebellum also plays cardinal roles in
affective regulation, cognitive processing, and linguistic function. Indeed, there is a growing recognition that
disruptions of cerebellar development cause considerable cognitive, behavioral, and social deficits. Yet, though
cerebellar malformations are amongst the most commonly recognized structural brain malformation in prenatal
imaging, reliable information about their cause is sparse. Diagnosis is based on imaging studies which are
often unreliable, a problem amplified during development. In stark contrast to the wealth of knowledge gained
over the decades regarding the mechanisms and genes driving cerebellar development in mice and other
model organisms, we actually know very little about human cerebellar development. We recently reported
multiple aspects of human cerebellar development significantly differing from mice and even rhesus macaque,
a non-human primate. These discoveries challenge our current mouse-centric models of normal cerebellar
development and the pathogenesis human cerebellar developmental disorders. This proposal seeks to
advance knowledge of normal developing human cerebellum and cerebellar birth defects, leveraging 1) our
unique access to normal and abnormal human cerebellar developmental data and 2) our extensive, specific
expertise of mouse and human cerebellar development and our deep knowledge of human cerebellar
malformations. Our detailed characterization of normal and abnormal cerebellar development, combined with
humanized mouse models will improve our understanding of the biology of normal human cerebellar
development and the pathogenesis of a clinically important human cerebellar birth defect, Dandy-Walker
malformation (DWM). Our experiments will provide gold standard datasets to assess model systems of human
cerebellar development, generate the first “humanized” mouse models of human cerebellar development and
finally, enable improved and sorely needed prenatal diagnostic information for families affected by cerebellar
malformations.

Public health relevance
PROJECT NARRATIVE Human cerebellar malformations are clinically important birth defects that cause substantial morbidity and mortality and are poorly understood. Cerebellar involvement is also central to common neurodevelopmental disorders, including Autism and Intellectual Disability, yet very little is known about human cerebellar development. These experiments are designed to fill a considerable knowledge gap regarding the cellular and molecular programs that drive normal human cerebellar development and the pathogenesis of human cerebellar malformations.